Evaluating the Influence of an Improved Piped Water Network on Water Quality and Gut Microbiome Composition Among Children in Mozambique

PROJECT SUMMARY/ABSTRACT
The gut microbiome plays a significant role in immune function, infection resistance, cognitive function,
metabolism, and growth. The first year of life is a critical period for the development of a healthy and diverse gut
microbiome. Enteropathogen infection and heavy metal exposures have also been associated with measurable
changes in gut microbiome composition - a primary route of exposure being consumption of contaminated
drinking water. While we know that gut microbiome composition is heavily influenced by early environmental
exposures such as mode of delivery and diet, there are key gaps in our understanding of the impact of other
environmental exposures, specifically drinking water, on the developing gut microbiome. I hypothesize that
drinking water quality, and associated factors such as reliability and access, is associated with gut microbiome
composition during the first year of life. Access to a safely managed water supply is critical for health and well-
being. Interventions to improve drinking water access and quality often fall short of achieving measurable health
gains, possibly because the intervention fails to effectively reduce contamination and sustainably increase
access. Comprehensive, reliable estimates of exposure are necessary to understand why an intervention
achieved – or failed to achieve - expected health gains, but reliable estimates of exposure are rarely used in
practice. Specific Aim 1 in this proposal aims to address this gap by comprehensively evaluating whether or not
a large-scale intervention (i.e., the provision of an improved piped water network) is effective in reducing
microbial and toxicological contamination and increasing water access. Results from this aim will improve our
understanding of the overall impact of a community-wide intervention on drinking water quality and access.
Specific Aim 2 will assess whether a large-scale water intervention is associated with differences in child gut
microbiome composition. This aim will fill knowledge gaps on the health effects of a large-scale water intervention
in low-income settings, which are sorely needed to improve child health. Specific Aim 3 provides the first
opportunity to assess whether drinking water quality, an important but overlooked environmental exposure in gut
microbiome research, is associated with gut microbiome composition among children. Since harms to the gut
influence health outcomes in addition to diarrhea, such as growth and metabolic function, investigating the
influence of drinking water quality on gut microbiome composition allows us to assess the total effects of water
quality on gut health. Results from this aim will provide insight into the relationship between water quality and
the gut microbiome, which is critical for understanding both acute and chronic health outcomes associated with
early perturbations to the gut.

Public health relevance
PROJECT NARRATIVE The gut microbiome, which begins to develop in early life, is associated with many important physiological functions. Harmful exposures during the first year of life (e.g., heavy metals and enteropathogen exposures that are prevalent in drinking water in low-income contexts) can cause gut dysbiosis, which is associated with many adverse health outcomes. This project will investigate if and how improvements to drinking water quality and access influence infant gut microbiome composition among children in Beira, Mozambique, which is critical to improve our understanding of the association between drinking water quality and access on both acute and chronic sequelae related to gut dysbiosis.